Administrative Core

ABSTRACT:
Core A (Administrative Core) is housed within the Center for Translational Science at Florida International
University and is led by the Program's Principal Investigator, Stephen M. Black, PhD, who will provide essential
administrative support and ensure the overall direction and organization of the entire Program. In addition, this
Core will provide accounting support to ensure appropriate fiscal and scientific oversight, monitoring, and
compliance with federal and institutional grant management regulations, the latter through several formal
mechanisms. The objectives of the Administrative core are: (i) to centralize all administrative actions and
financial recording keeping; (ii) to prepare scientific and financial reports as required by the university and the
NHLBI; (iii) to ensure that the PPG research meets the highest standards through periodic review by the internal
and external review panels; (iv) to facilitate the use of shared resources; (v) to provide the projects and cores
with a review of all expenditures monthly as well as dealing with University Accounting and Grants offices
concerning grant budgets; (vi) to provide the communication venues that foster exchange of scientific information
and ideas and allow seamless communication between PPG scientists including leaders of Project #1, Dr. Jeffrey
Fineman in San Francisco and Project #3, Dr. Ting Wang at FIU; (viii) to coordinate the travel arrangements
for Drs. Fineman and Wang to have quarterly face-to-face meetings with FIU PPG scientists. This
communication is vital to the program's success Core A personnel will organize video conferencing with Drs.
Fineman and Wang: i) weekly meetings of individual Project and Core teams, ii) biweekly meetings of the
Program Committee (led by Core A Leader and PPG PI) where Project and Core leaders discuss scientific and
administrative matters, and iii) regular monthly research seminars that will allow PPG investigators to present
their work in progress to other researchers. Core A personnel will also facilitate workflow between Port St. Lucie
and San Francisco regarding Cores B and C experiments and the critical exchange of reagents between
Projects. Finally, Core A will coordinate the inter-project and inter-institutional collaborative arrangements and
evolve new arrangements as deemed necessary for the scientific progress of the Program Project as a whole.
Together, these coordinated administrative services will ensure optimal purchasing practices, facilitate frequent
and productive communications between PPG scientists, and promote the high-quality scientific interactions
necessary to meet the goals of this translational PPG.

Public health relevance
RELEVANCE: Core A will provide administrative support, organization, coordination, and efficient management while overseeing communication planning for this PPG application.